Dysregulated DNA replication forks as targets for formaldehyde mutagenesis

Project Summary
Formaldehyde is a class I carcinogen and is present in the environment and generated endogenously by cells.
Formaldehyde has been shown to form DNA-base adducts and DNA-protein crosslinks, both of which contribute
to formaldehyde-induced genomic toxicity. My preliminary data using an inducible single-stranded DNA (ssDNA)
system in yeast has shown that formaldehyde preferentially mutagenizes ssDNA and that this mutagenesis is
dependent on translesion synthesis and DNA-protein crosslink repair. Currently, it is unknown which sources of
endogenous ssDNA act as targets for formaldehyde-induced mutagenesis. Without this knowledge, it is
impossible to know which individuals are at elevated risk for formaldehyde-induced carcinogenesis. One of the
major sources of ssDNA is at replication forks. While ssDNA production at replication forks is typically tightly
regulated, several human disorders cause fork dysregulation and ssDNA accumulation. Therefore, my central
hypothesis is that ssDNA generated at dysregulated replication forks is a preferential substrate for formaldehyde-
induced mutagenesis. Aim 1 will employ a sensitive mutational reporter in yeast to investigate dysregulated
replication forks as substrates for formaldehyde-induced mutagenesis. This will be done via replicative
polymerase knockdown and manipulation of the replication fork protection complex. In aim 2, I will investigate
replication-associated ssDNA as a preferred formaldehyde substrate in human HepG2-aldh2-/-. Replication
stress will be induced with hydroxyurea and cells will be treated with formaldehyde to determine a formaldehyde-
induced mutational signature in human cells. Additionally, cells will be treated with the translesion synthesis
inhibitor JH-RE-06 (REV1) or the DNA-protein crosslink repair inhibitor 1,10-Phenanthroline (SPRTN) to
determine the roles of these pathways on formaldehyde mutagenesis in human cells. Using this combination of
yeast reporter systems and human cells, I will investigate replication forks as preferential targets for
formaldehyde-induced mutagenesis. The findings of this work will be significant because it will identify individuals
who are “at-risk” for formaldehyde-induced carcinogenesis and establish a formaldehyde-specific mutational
signature in human cells that can be used to track long-term environmental exposures to formaldehyde. This
research will be performed at the Medical University of South Carolina under the mentorship of Dr. Natalie Saini
and Dr. David Long. The Department of Biochemistry and Molecular Biology and the Hollings Cancer Center
both have well established and effective programs for student training. Being the only Ph.D. student in the Saini
lab, I have gotten an extremely personalized and hands on training experience, and Dr. Long contributes
significant mentorship experience to my training plan. This proposal outlines the experimental and professional
development goals for my training as I prepare for a career as an independent principal investigator at a
research-focused institution.

Public health relevance
Project Narrative Despite its environmental abundance and known role as a class I carcinogen, little is known about the genomic substrates that are most at risk for formaldehyde-induced mutagenesis. Our preliminary data has shown that single-stranded DNA is preferentially mutagenized by formaldehyde, and we propose investigating replication forks as a cellular source of single-stranded DNA that could be targeted by formaldehyde. Given that there are several DNA repair and replication disorders that are associated with abundant single-stranded DNA, this work could identify individuals that are “at-risk” for formaldehyde-induced carcinogenesis.